Comparing NK cell profiles within melanoma tumors and pregnancy: Implications for novel immunotherapies

PROJECT SUMMARY:
Despite the advent of immune-checkpoint blockade (ICB), melanoma remains a deadly skin cancer. Notably, the
indication for ICB therapies continues to expand for melanoma, and they are now used in the adjuvant,
neoadjuvant and first-line treatment settings. However, these agents can have deadly side effects and the field
remains unable to predict response to these agents. Therefore, refining our ability to predict (A) patients with
early-stage disease at high risk of disease progression who would benefit from ICB adjuvant therapy and (B)
patients who will not respond to ICB treatment remains a top priority in melanoma, and cancer research more
broadly. To address these clinical needs, in this proposal we will study primary tumor invasive capacity to predict
risk of progression and tumor immune evasion mechanisms to predict response to ICB therapy. Interestingly,
placentation (the formation of the placenta) is a naturally occurring model in which fetal tissue invades into the
maternal uterine line (decidua) and evades maternal immune cell destruction. Indeed, there is strong evidence
that cancer cells can co-opt mechanisms that evolved for placentation to increase their own malignant potential.
The cell type that regulates placentation is called a decidual Natural Killer cell (dNK cell) that, unlike circulating
NK cells, is proangiogenic and immunoregulatory. NK cell function is largely regulated by Killer-immunoglobulin
like receptors (KIRs) and dNK cells express very high levels of KIRs that bind to HLA-C expressed on invading
fetal cells. This interaction promotes tissue invasion and immune evasion during placentation. Importantly, the
KIR/HLA-C interaction is highly polymorphic, leading to varied NK cell effector functions across individuals and
specific KIR/HLA genotypes are associated with disorders of placentation. Therefore, KIR/HLA genotypes
impacting NK cell function within melanoma patient could potentially explain differing therapy responses. Notably,
decidual-like NK cells (dl-NK cells) with similar immunosuppressive and proangiogenic functions have been
reported in numerous other solid cancers and we have exciting preliminary data showing that these cells are
also present within melanoma tumors and express high levels of KIR. Therefore, we hypothesize that the
KIR/HLA axis acting on dl-NK cells facilitates both tissue invasion (Aim 1) and immune evasion (Aim 2)
in melanoma. To test this hypothesis, we will use state-of-the-art techniques including multiplexed
immunohistochemistry, single-cell spatial transcriptomics, patient derived organoid models and high-resolution
allelic level sequencing of the KIR/HLA loci, to evaluate these mechanisms. Our primary objective with this
proposal is to identify biomarkers that will predict risk of disease progression and response to ICB therapy. Our
secondary objective is to define new therapeutic targets to either limit disease progression or improve response
to ICB therapy.

Public health relevance
PROJECT NARRATIVE Treatment of malignant melanoma has dramatically improved, but many patients either do not respond or develop severe side effects to the now standard immune checkpoint blocking agents. Surprisingly, there is strong data indicating that mechanisms that evolved to facilitate a healthy human pregnancy can be hijacked by cancer cells to increase their metastatic capacity and avoid immune destruction. Therefore, we will compare mechanisms that promote tissue invasion and immune evasion found in both pregnancy and cancer with the goal of identifying (1) biomarkers to predict risk of disease progression and treatment response and (2) novel therapeutic targets.